Examining the Role of Central Sensitization with Aging: an Investigation of Older Adults with and without Chronic Low Back Pain

PROJECT SUMMARY/ABSTRACT
Chronic pain affects over 5 million older adults every year in the United States. This burden is expected to
worsen in the coming years given that the general population is aging, chronic pain prevalence is inordinately
high among older adults, and it is unknown why aging is a risk factor for chronic pain disorders. The National
Institute on Aging is keenly aware of this impasse, as evidenced by requests for research to focus on the
“elucidation of mechanisms underlying pain experience and its consequences in aging”. Literature has
established sensitization of the central nervous system (termed central sensitization) as an impairment that
amplifies pain perception in young and middle aged adults with chronic pain, leading to pain persistence and
resultant disability. However, a paucity of research has evaluated the presence and consequences of central
sensitization in geriatric chronic pain conditions, including chronic low back pain. This gap in knowledge is
further complicated by a lack of understanding whether central sensitization occurs with aging, and an absence
of definitive diagnostic criteria for central sensitization. Therefore, the goals of this proposal are to elucidate if
and how central sensitization develops as a result of biological aging, and characterize the presence and
clinical implications of central sensitization in older adults with chronic low back pain. In Aim 1, we will
determine the extent to which older adults with chronic low back pain demonstrate increased static and
dynamic pain sensitivity compared to older and younger adults without chronic pain. For Aim 2, we will quantify
differences in experimentally-induced sensitization between these three groups. In Aim 3, we will examine the
relationship between indicators of central sensitization and clinical measures of pain, physical function and
perceived disability among older adults with chronic low back pain. The central hypothesis of this proposal is
that older adults with chronic low back pain will demonstrate the greatest magnitude of central sensitization,
which will be associated with greater clinical pain intensity, poorer physical function, and worse perceived
disability. The results have the potential to inform primary, secondary and tertiary prevention efforts by
determining if CS occurs with biological aging, optimizing the identification of CS by combining standard and
novel measurement methodologies, and providing foundational evidence for a potentially modifiable
mechanism that burdens older adults with chronic low back pain, respectively. This proposal is a critical first
step towards the long-term goal of this fellowship applicant, which is to improve primary, secondary and tertiary
prevention efforts for vulnerable chronic pain populations by quantifying and intervening upon mechanisms
(such as CS) that underlie maladaptive pain sensitivity. Additionally, this fellowship proposal will provide the
applicant with structured training from mentors with expertise in gerontology, pain science and rehabilitation;
this training will not only facilitate completion of this research project, but also prepare the applicant for a
career as a productive clinician scientist.

Public health relevance
PROJECT NARRATIVE In order to optimize pain management strategies and mitigate the chronic pain crisis, there is an urgent need to investigate impairments (i.e., maladaptive pain sensitivity) that may predispose older adults to the development or persistence of chronic pain. This project will examine central nervous system sensitivity to pain (i.e., central sensitization) across older adults with chronic low back pain, older adults without chronic pain, and younger adults without chronic pain. The findings will advance our ability to quantify and understanding of central sensitization in older adults with and without chronic pain; as such, this work has the potential to improve how a risk factor for chronic pain development and persistence is identified, classified, and treated in older adults, thereby improving the quality of care for older Americans with chronic pain.